University of Miami Developmental HIV/AIDS Mental Health Research Center (D-ARC)

Project Summary (Overall)
This application from the University of Miami (UM) for a Developmental AIDS Research Center (UM D-
ARC) proposes to establish a behavioral science hub advancing mental health (MH) HIV research in a US
region hardest hit by HIV/AIDS. The over-arching Center theme, “Reducing the Impact of Mental Health
and Minority Health Disparities across the HIV Prevention and Care Continua,” is directly relevant to the
uncontrolled HIV/AIDS epidemic in the Greater Miami area, and this developmental funding will provide a
pathway for dynamic growth to a subsequent full ARC application. Over the initial funding period, we will
consolidate, coordinate, and augment institutional resources as well as develop and expand regional and
national collaborations. Miami has the highest HIV incidence and prevalence of any US city and fares worst,
geographically, on every CDC indicator of HIV impact. Developing a D-ARC focused on MH at UM is also of
high public health significance, as Miami’s diverse populations face significant MH disparities, making the area
an ideal setting for MH research across diverse populations disproportionately affected by the epidemic.
The organization of the UM D-ARC Cores represents a logical and innovative approach to establishing a
D-ARC in an institution that has a growing cadre of behavioral scientists and a strategic goal of increasing HIV
research. We propose the required Administrative (Admin) Core and Developmental (Dev) Core and two
(rather than the required one) complementary Research Cores: a Methods Core and a Mental Health
Disparities (MHD) Core. The Admin Core will embody Center leadership, governance, and strategic planning
and coordinate the bi-directional community engagement activities that are key to the work of all Cores. The
Dev Core will focus on awarding pilot studies and mentoring early stage investigators. The Methods Core will
provide innovative research design, biostatistical, and data management expertise and collaborate with the
MHD Core to construct, expand, and maintain Center Common Data Elements (CDE), consent-to-contact
databases, and a REDCap measures library to maximize resource sharing. The MHD Core will provide
expertise and resources to promote culturally competent, theory-driven approaches, tools, and interventions in
ethical, multi-level, community-engaged research addressing MH and minority health disparities in HIV.
The developmental activities proposed for the new UM D-ARC have the overarching goal of increasing
local MH HIV/AIDS research consistent with the center theme and UM strategic goals regarding HIV/AIDS and
will leverage strong institutional support. This structure allows for attainment of our Overall Aims, which are to
establish the Developmental Center, and to grow by promoting research that mitigates the impact of MH and
minority health disparities across the HIV prevention and treatment continuum. The UM D-ARC has the unique
potential for high-impact research addressing HIV among hardest-hit populations in greatest need and at
greatest risk for falling off of the HIV prevention and treatment continua.

Public health relevance
PROJECT NARRITIVE This proposal for what would be the first NIMH Developmental Mental Health HIV/AIDS Center (D- ARC) from the University Of Miami (UM) has exceptionally high public health significance; the D-ARC would be situated in one of the hardest hit geographic areas affected by the epidemic, at an institution with a strong and growing faculty of mental health HIV/AIDS researchers with ties to the local health departments, and to the local community. The proposed D-ARC will catalyze high-impact research efforts addressing mental health disparities, answering key questions related to HIV prevention and care starting in a domestic epicenter, with implications that can be applied broadly, and stimulate growth to a full-fledged MH-ARC. The focus of expertise and center activities on those most at risk for not achieving U.S. and U.N. end-the-epidemic goals is an excellent match for the geographic area facing health and mental health disparities driving the HIV epidemic.